Equipment upgrade for 7T Small Animal MRI system

Project Summary
This shared instrumentation proposal request funds to support the upgrade of the 7T magnetic resonance
imaging (MRI) system at the UCSD Center for Functional MRI (CFMRI). The current system utilizes a Bruker
AVANCE II console that was installed in 2007. Bruker is no longer guaranteeing support for the AVANCE II
platform and the inventory of available spare parts for the console is rapidly dwindling. As a result, the
likelihood of prolonged periods of downtime on the system is continually increasing and threatens the ability to
carry out a wide range of ongoing NIH-funded projects at UCSD, including studies of cancer, osteoarthritis,
heart failure, and memory. An upgrade to a console (AVANCE NEO) that is fully supported by Bruker is critical
to minimize downtime and ensure the success of these important projects. As the AVANCE NEO console is
designed to work seamlessly with the existing Bruker 7T USR magnet at the CFMRI, the proposed upgrade will
ensure a smooth transition to a solution that can readily support the progress of ongoing NIH-funded studies.

Public health relevance
Project Narrative (Relevance to Public Health) The proposed system upgrade is necessary to support ongoing NIH-funded studies that are focused on (1) developing new imaging methods for the diagnosis of disease and (2) achieving an understanding of the basic mechanisms underlying health and disease. These studies are likely to result in the improved diagnosis and treatment of a number of health conditions, such as cancer, osteoarthritis, and heart disease.